Core 1: Shared Resource Core (LCRSRC)

Linguistic and Cultural Responsiveness Shared Resource Core (LCRSRC)
The CCNY-MSK Partnership continues to grow the LCRSRC for this next Partnership cycle, to respond to the
tremendous need for linguistic and cultural inclusiveness to reduce cancer disparities, and to leverage the great
strengths, expertise, and tools of the U54 partners in this area. The LCRSRC's goal is to provide linguistically
and culturally responsive support to the U54 Partnership Cores (Research Education, PCORE), Research
Projects, and Working Groups (Immunotherapy Access, Biomedical Engineering, Health Policy, Discrimination
and Health), and to build the capacity of U54-connected researchers and community members to reduce cancer
disparities by conducting community-engaged, culturally and linguistically inclusive translational research,
outreach, education, and navigation. The specific aims of the LCRSR are: 1) to provide research consultation
support and training in the selection and/or design of specific linguistically and culturally responsive quantitative
survey tools, research study materials, educational materials, and practices for the U54 Research Projects,
PCORE, and Research Education cores; 2) to assist CCNY, MSK, and community U54 investigators in the
design, implementation, and analysis of qualitative research with diverse populations: to assist in the translation
and transcreation of focus group, key informant, and in-depth interview guides; to provide multilingual focus
group, key informant, and in- depth interview facilitation, and multilingual transcription and translation services
for qualitative studies; 3) to access the CCNY Grove School of Engineering expertise to enable U54-linked
studies and programs to utilize remote simultaneous medical interpreting (RSMI) (UN-style interpreting) to
enable seamless communication between LEP community members, researchers, and PCORE, including with
a focus on precision medicine/precision prevention and immunotherapy: (a) to utilize this resource to help enable
MSK Integrated Mutation Profiling of Actionable Cancer Targets to Eliminate Disparities (IMPACTED) genomics
studies to engage LEP patients at community cancer centers and facilitate genetic testing and shared decision
making; (b) to utilize RSMI to help engage community members in clinical trials, precision screening and
prevention, and immunotherapy education, services, and studies; and (c) to continuously monitor Artificial
Intelligence (AI) potential as a simultaneous medical Interpretation resource, with its potential efficiencies of scale
and capacity for almost unlimited dissemination; and 4) to support the dissemination of the CCNY Minor/Major
in Medical Interpretation and Translation, to impart to bilingual CCNY students the skills to provide translation
and interpretation services for cancer outreach, education, service delivery, and research, and to build the
LCRSRC capacity in these areas. The LCRSR will improve the way that translational cancer research activities
and services reflect the rich linguistic and cultural diversity of our surrounding communities, our city, and
ultimately, through model dissemination, the nation.

Public health relevance
As per solicitation PAR-23-308 Comprehensive Partnerships to Advance Cancer Health Equity (CPACHE) (U54 Clinical Trial Optional) Project Narrative: Do not complete